Expanding the Value of the EARLI study: Small Cohort with Big Data

Neurodevelopmental disorders (NDDs), including ASD, affect over 15 percent of US children –
Autism Spectrum Disorder (ASD) alone affects approximately 1.5% of US children. Identification
of underlying causes can lead to primary and secondary prevention efforts. Substantial evidence
supports contribution of both genes and environment, particularly prenatal exposures.
Prospective studies, with exposure information collected during pregnancy, prior to symptom
onset, are sorely needed although prospective studies in the general population are not feasible,
cost effective, or efficient for ASD. The enriched-familial-risk design, which capitalizes on the
substantial recurrence risk of both ASD and NDD among siblings of children with ASD, has been
employed to achieve prospective data collection with reasonable outcome events. The Early
Autism Risk Longitudinal Investigation (EARLI) study has helped to trailblaze this enriched risk
cohort approach. EARLI recruited and followed over 260 pregnant women who already had a
child with ASD with multiple study visits, child assessments, biosampling, and home environment
surveys over pregnancy and the first 3 years of life. While the total sample size was constrained;
the value of EARLI is the depth of longitudinal data and molecular measurements across multiple
tissue types and early developmental windows. To date, over 9.4 billion data points have been
generated across multiple phenotypes, tissues, exposures, and -omic measures. The current
proposal seeks to maintain and enrich this valuable study to fully realize its impact on
environmental health. The goals are to: 1. Maintain and extend the EARLI Biosample Repository
through support of the storage and retrieval efforts and addition and storage of shed baby teeth
that will enable longitudinal prenatal exposure measures across a growing array of toxicant
exposures. 2. Measure frequency and patterns of emerging co-occurring conditions at school age
to better characterize phenotypes across co-occurring NDDs and quantitative traits. 3.
Characterize variability of heavy metals measurement across timing, family members, and
matrices including maternal blood and urine and shed baby teeth. 4. Develop and apply methods
for phenotype and for exposure harmonization using latent constructs, enabling within and cross-
cohort investigations; 5. Migrate, enhance, and increase the reproducibility of EARLI research
data to enable data sharing. The EARLI study is a valuable asset to early life environmental
epidemiology of neurodevelopmental outcomes. Conducting these aims will allow us to maximize
the contribution of this novel study to the understanding of ASD and NDD etiology.

Public health relevance
A better understanding of what causes autism and other neurodevelopmental disabilities can lead to better treatment and ultimately prevention of onset or disabilities. Although we know genes and prenatal and early life environments play a role, we do not yet understand the specific factors and need rigorous studies that follow pregnancies and early childhood factors as they occur, prior to symptom onset. The EARLI study is designed in this way, with many types of data about environments, medical conditions, early child development, and biological samples like blood, urine, hair, semen and placenta that can contribute to the child environmental health research community.